Deleted in malignant brain tumors 1 (DMBT1) expression and impact on colonic dysplasia

PROJECT SUMMARY/ABSTRACT
Bacteria-host interactions are emerging as critically important mechanisms for cancer progression but are poorly
defined in precancerous colonic dysplasia. Host proteins responsible for maintaining the bacteria-resistant
barrier in the colon can also function as regulators of epithelial cell differentiation and growth, such as Deleted
in Malignant Brain Tumors 1 (DMBT1). DMBT1 is a secreted glycoprotein highly expressed at epithelial barrier
sites in the human gastrointestinal tract. Published data show DMBT1 is upregulated in gastric metaplasia and
gastric adenocarcinoma, but the expression and mechanistic role of DMBT1 in colonic precancerous lesions
is unknown. Recent research suggests DMBT1 slows epithelial proliferation and may inhibit the development of
colorectal cancer (CRC). My preliminary data show the DMBT1 gene is downregulated in distal colonic dysplasia.
Our spatial transcriptomics data reveals downregulated DMBT1 expression in dysplastic foci compared with
normal colonocytes. In mouse colon tissue, I use immunofluorescence to characterize DMBT1 protein
expression. The DMBT1 staining is predominantly in mid-crypt colonocytes with cytoplasmic localization and
enhanced staining near the apical border. I further show DMBT1 expression in 3 different mouse models of CRC:
azoxymethane/dextran sodium sulfate, C. difficile-associated tumorigenesis in Apcmin, and Lrig1CreER/+;Apcfl/+
mice. In 100% of the dysplastic foci (n = 57 foci from 11 mice), the immunofluorescent staining of DMBT1 protein
is reduced in precise correlation with upregulated β-catenin. Analysis of DMBT1 expression in human CRC
samples, including tissue microarrays containing early dysplasia, shows DMBT1 protein localization and
abundance correlates with disease progression. Specifically, more advanced pathologies correlate with DMBT1
loss or secretion. Based on my preliminary data and published literature, it appears DMBT1 may function as a
tumor suppressor specifically acting in early CRC dysplasia. Previous studies show DMBT1 is transcriptionally
regulated via canonical innate immune signaling pathways (e.g. NF-κB, STAT3) in infection and inflammatory
bowel disease. However, the critical pathways mediating DMBT1 downregulation in colonic dysplasia are
unknown. My hypothesis is that reduced DMBT1 expression in colonic dysplasia is transcriptionally
regulated and provides a selective advantage for tumorigenesis through hyperproliferation and altered
cell polarity. To test this, I will determine the timeline and mechanism of DMBT1 loss using CRC mouse models
and biochemical and genetic manipulations of cellular pathways commonly dysregulated in CRC (Aim 1), and I
will determine how loss of DMBT1 might be advantageous for tumor development in CRC by establishing DMBT1
knockout (DMBT1 -/- ) cells, human organoids, and a DMBT1 -/- CRC mouse model. Potentially, the loss of DMBT1
staining may aid with clinically distinguishing dysplasia from reactive changes in inflammatory bowel disease
and provide a biomarker for early dysplastic transformation in human CRC.

Public health relevance
PROJECT NARRATIVE Deleted in Malignant Brain Tumors 1 (DMBT1) is a large, secreted glycoprotein that may represent a critical link between inflammation, infection, and colorectal cancer (CRC). The proposed research will investigate the mechanism of DMBT1 loss in colorectal dysplastic transformation and determine if DMBT1 loss is advantageous for CRC progression through changes in epithelial cell survival, proliferation, differentiation, and migration potential. Understanding the molecular relationships between immune barrier function and the regulation of epithelial homeostasis will ultimately improve CRC biomarker discovery and precancer diagnostics.